Metalloenzyme structure, function and assembly

The combination of metal ions with proteins offers unique chemical reactivities that are at the heart of many of Nature’s most important and amazing chemical transformations. For example, metalloenzymes catalyze the reduction of ribonucleotides to deoxyribonucleotides, a rate-limiting step in DNA biosynthesis. They biosynthesize anticancer and antiviral compounds and vitamins that have unusual scaffolds. Our lab employs structural methods to interrogate how metalloenzymes are able to perform this incredible chemistry. We seek to understand how the architecture of metalloenzymes allows for radical species to be controlled – i.e. turned off, turned on and harnessed – to enable the reaction at hand. We also strive to understand how proteins are designed to enable long-range electron transfer without protein damage or radical loss. In this proposal, we describe structural studies of our metalloenzyme model systems, including class Ia (diiron-dependent) and class III (glycyl radical-dependent) ribonucleotide reductases that allow us to interrogate the molecular basis of radical-based chemistry. We also describe efforts to understand how protein scaffolds facilitate organometallic chemistry. These studies leverage both our expertise in working with O2-sensitive metalloenzymes and in cryogenic-electron microscopy (cryo-EM). Although we will continue to employ X-ray crystallography, cryo-EM is proving to be a game-changer for many of our metalloenzyme systems. In particular, the resolution revolution of cryo-EM provides us with the means to obtain long-awaited structures of both large and transient metalloprotein complexes and to determine structures of metalloenzymes in functionally-essential conformational states that were previously unattainable by crystallography. The results of our structural studies will enable structure-based design of novel antibiotics targeting, for example, microbial ribonucleotide reductases. They will aid our understanding of human ribonucleotide reductase, a major cancer drug target. These structural data will also guide efforts to exploit radical enzymes for the production of medically important compounds with unusual scaffolds.

Public health relevance
Understanding and being able to manipulate metalloenzyme biochemistry has applications for many aspects of human health and biotechnology (e.g. the production of novel antibiotics and anticancer drugs). With antibiotic resistance emerging as a major health concern and our battle with cancer ongoing, the proposed studies are important and timely, and the efforts will result in insights necessary to combat these frontier challenges.